Flow Cytometry Core

PROJECT SUMMARY: Flow Cytometry Core
The Vanderbilt Digestive Disease Flow Cytometry Core (VDDFCC) is an established and highly utilized Core
supported by the VDDRC. It was developed in direct response to member requests and approved by the
Executive Committee and the Scientific Advisory Board with substantial institutional support provided by
Vanderbilt. This Core provides state-of-the-art equipment for analytical spectral flow cytometry, classical flow
cytometry, and cell sorting. To complement this technology, the VDDFCC provides expert consultation on
experimental design, optimization, and analysis along with a multi-tiered approach to a customizable training
program for VDDRC members. Sixty VDDRC members have benefitted from this Core over the current funding
period which led to 90 peer-reviewed original publications. The VDDFCC maintains 4 classical analytical
cytometers, 3 cell sorters and a spectral flow cytometer that has been acquired within the current funding period.
The spectral flow cytometer uses 48 channels for fluorescent detection, which allows VDDRC investigators to
maximize panel design for rare and critical samples. Training is accomplished through both group and individual
interactions to develop and maintain the highest proficiency with these technologies. Trained users have the
ability to utilize the analytical cytometers on a 24 hour/7 days a week basis, 365 days a year. VDDRC members
have also benefitted from collaborations between the VDDFCC and other VDDRC Cores such as the
Translational Analysis Core and the Cell Imaging Core, as well as institutional shared resources such as the
Vanderbilt Technologies for Advanced Genomics Core (for single cell and single nucleus isolation and
RNASeq) to enhance their digestive disease research discoveries. Digestive disease research often requires
customized modification of instrumentation settings, configuration, and on rare occasions fabrication of
specialized parts to increase an instrument’s capability. The VDDFCC works closely with the instrument
manufacturers to facilitate these modifications. Specific recommendations for adipose tissue multicolor panel
design, isolation of nuclei from intestinal tract samples, and optimized conditions for sorting intestinal and gastric
organoids are just a few examples of digestive disease-specific services regularly provided by the VDDFCC to
VDDRC members. The VDDFCC has also implemented specific open-office hours exclusively available to
VDDRC members for the sole purpose of elevating and accomplishing digestive disease research at Vanderbilt.
As a shared resource, the VDDFCC offers access to technologies, services, and expertise to all VDDRC
members unattainable by most individual labs due to high costs and field-specific experience. In sum, the
overall strategy and goals of the VDDFCC are specifically guided by the needs of VDDRC members, which
consequently adds depth and impact to their studies, allowing this Core to function as a scientific catalyst for
new discoveries.